University of Massachusetts Center for Clinical Science and Translational Supplement

PROJECT SUMMARY/ABSTRACT This proposal is submitted in response to the National Center for Advancing Translational Sciences (NCATS) Notice of Special Interest (NOSI; NOT-TR-20-014) seeking UL1 Administrative Supplements to add a dedicated CTSA hub quality assurance/quality control position.

Public health relevance
PROJECT NARRATIVE This proposal adds a dedicated CTSA hub quality assurance/quality control position to provide robust quality assurance and project management services to UMCCTS faculty and staff and to evaluate the effectiveness and impact of the UMCCTS Quality Control Program and Project Management Consult Services.